Highly Sensitive Liquid Chromatograph Tandem Mass Spectrometer (LC-MS/MS) for Shared Research at Emory University

PROJECT SUMMARY
We propose to acquire an ultra high-performance liquid chromatograph coupled with a SCIEX triple quadrupole
7500 tandem mass spectrometer (SCIEX 7500 LC-MS/MS) to be housed in the Targeted Analysis Core (TAC)
in the Rollins School of Public Health at Emory University. The TAC provides analytical laboratory services for
multi-media characterization and quantification of environmental contaminants and clinical biomarkers to
several Emory research centers. The proposed instrument is state-of-the-art and delivers the highest level of
speed, performance, and sensitivity currently available. Acquisition of this instrument will transform the sample
processing capacity of the core with high sensitivity and robust quantification and allow effective assessment of
exposures to a variety of well-known and emerging contaminants and biomarkers in exposure and
epidemiological studies ongoing at Emory. NIH-funded Emory research centers will benefit immediately from
the new features of the instrument. Researchers from these centers will make use of this instrument to enable
a wide range of basic and biomedical research studies aimed at better understanding of the effects of
environmental exposures on human health. While this instrument will be mainly used by the major user group,
we expect it to impact many other researchers as well. The instrument will be supported by the TAC team with
exceptional expertise in analytical chemistry and in providing training and support for high quality
environmental exposure assessment.

Public health relevance
PROJECT NARRATIVE The requested ultra high-performance liquid chromatograph coupled with a triple quadrupole tandem mass spectrometer (LC-MS/MS) will provide essential analytical capabilities for NIH-funded research centers at Emory University serving scientists conducting research in environmental health sciences. The instrument will enable public health researchers to advance our understanding of health risks of environmental exposures to chemical contaminants.